Biologics - gap analysis services

The NINDS has a need for biological therapeutics development subject matter expert (SME) consultants to provide technical recommendations and advice that will support the development of milestones for drug discovery and development projects. The support included in this contract will cover milestone development for pre-award projects.